Therapeutic and Catalytic Applications of Electroactive Bacteria

Abstract
Electroactive bacteria couple changes in the extracellular reduction-oxidation (redox)
environment to their central carbon metabolism through extracellular electron transfer (EET).
Several electroactive commensals and pathogens have been isolated from the human gut, oral
cavity, and other locations, but their influence on host biology has not been examined.
Accordingly, the overall goal of the proposed work is to uncover the fundamental role that EET
plays in human health and to exploit this understanding to develop new therapeutics and
biological catalysts. Building off our previous efforts studying the electroactive bacterium
Shewanella oneidensis, we will first select for new-to-nature reactivity by engineering electron
transfer proteins that couple the desired chemical reaction to cell growth. We hypothesize that
EET can significantly accelerate the rate of new biological reaction discovery. Next, we will
examine the role of EET in the healthy and diseased gut microenvironment. We hypothesize that
EET contributes to iron homeostasis and will explore this possibility by combining animal models
of gut dysbiosis with a novel droplet microfluidic assay capable of detecting electroactive bacteria
in complex ex vivo samples. Finally, we hypothesize that electroactive probiotics can facilitate
EET-driven health outcomes. Towards this goal, we will transfer EET-capable proteins to
therapeutically relevant bacterial hosts and lay the groundwork for future in vivo and therapeutic
applications that exploit our understanding of EET’s role in disease biology. Overall, our proposal
will examine the fundamental role of EET in human health and apply this knowledge toward
advancements in biocatalysis and therapeutic development.

Public health relevance
Narrative / Public Relevance Electroactive bacteria can conduct electricity using extracellular electron transfer (EET), but the impact of this process on human health has not been explored. We will examine the fundamental role that biological electron transfer plays in human health, specifically iron homeostasis, and develop it into a tool for discovering new biological reactivity. Overall, our proposal combines advances in chemical biology, synthetic biology, and microbiology to uncover the health relevance and therapeutic potential of extracellular electron transfer.